Inducing Xenotolerance via Chimeric Thymus

ABSTRACT: Inducing Xenotolerance via Chimeric Thymus
Lack of sufficient organ donors currently limits the availability of life-saving organ transplantations in
humans. Transplantation of organs from genetically modified pigs has been proposed as a way of
overcoming this limitation, but success has thus far been limited by relatively short survival of pig xenografts
in humans. Inducing tolerance that provides specific unresponsiveness to donor pig tissues while
maintaining otherwise normal immune function could make xenotransplantation feasible for long-term,
definitive organ replacement. Tolerance to self-antigens normally develops as the result of positive and
negative selection of T cell precursors as they develop within the thymus. Our pivotal prior work established
that human allogeneic cultured thymus tissue implantation (CTTI) into athymic human recipients results in
robust immunity, with a functional donor-recipient chimeric thymus that generates T cells that are tolerant to
both recipient and donor antigens. Previous studies by others have shown that porcine thymus can interact
with human cells and promote some degree of xenotolerance in animal models. However, those models
generally have required fetal thymus tissue and their human cells have suboptimal immune function. Here,
we will leverage our unparalleled expertise as developers of CTTI and its success in inducing robust
immunity and donor-specific tolerance in athymic humans to provide critical proof of concept that
xenogeneic CTTI can generate xenotolerance in human T cells. The specific aim of this proposal is to
determine the ability of cultured postnatal pig thymus slices to attract human thymocyte precursors and
antigen presenting cells (APCs) and to support positive and negative selection in vivo in humanized
immunodeficient mouse models. These studies will contribute to the understanding of factors important in
normal thymus function, facilitate optimization and engineering of cultured thymus slices to enhance
tolerance induction, and advance development of strategies to induce tolerance toward allogeneic and
xenogeneic solid organs.

Public health relevance
PROJECT NARRATIVE/RELEVANCE This study will investigate challenges that must be overcome for pig thymus to attract, interact with, and support the development of human T cells and to enable engineering of chimeric cultured thymus tissues that can drive the development of tolerance to pig xenoantigens. Results will facilitate the successful application of xenotransplantation to overcome the barrier of insufficient donor availability that currently limits the application of life-saving organ transplantations in humans.